Stroke Rehabilitation utilizing BCI technology

ABSTRACT
Each year nearly 800,000 people suffer a new or recurrent stroke in the United States. Approximately 85%
of these patients survive and require rehabilitation making it the leading cause of long-term disability in the
U.S. Approximately 4 million Americans are living with the effects of stroke and millions of
family/friends are caregivers. The estimated direct and indirect costs of stroke continue to escalate (e.g. in
2003 was $57 billion, 2008 was $65.5 billion, and for 2010 is estimated to be $73.7 billion). The mean
lifetime cost of ischemic stroke in the US is estimated at $140,048, including inpatient care, rehab, and
follow-up care. The majority of stroke costs are towards long-term care and rehabilitation (>
$100,000/patient). Stroke rehabilitation in the latter stages of stroke is limited because most health care
insurance pays only for limited rehabilitation visits (12-24 outpatient rehabilitation visits). Yet there is room
for improvement in terms of decreasing morbidity and improving functional independence in these stroke
patients, given that 1/3 of patients have some type of residual deficits.
Although there are already several rehabilitation techniques aimed at stroke recovery including
traditional physical-occupational-speech therapy, novel therapies such as constraint-induced movement
therapy, robot- aided therapy, Transcranial Magnetic Stimulation (TMS), virtual reality (VR), a number of
these suffer from issues of passive movement repetition, large equipment, personnel/time constraints,
and high costs. Furthermore few harness brain plasticity to derive therapeutic interventions.
The recommendations from the 2009 workshop sponsored by the NIH blueprint for neuroscience
research heralded the translation of neuroplasticity as key to developing guidelines for effective clinical
therapies in rehabilitation.
Aim 1: To investigate the efficacy of BCI-FES vs. standard FES(current standard of care), as measured
by changes in behavioral measures in stroke patients.
A more recent development has been the use of a more active rehabilitation approach that harnesses
brain plasticity in which brain thoughts inferred by EEG-based Brain Computer Interface (BCI)system are
linked to functional electrical stimulation (FES) of the muscles to replace or assist function that is lost in
neurologically impaired individuals. In recent animal and human studies, active stimulation by
coordinating central brain activation with peripheral movement has been shown to elicit greater functional
recovery than passive stimulation or peripheral movements. This is presumably through the faster
formation of latent plastic neural circuits between central and periphery which an active approach would
foster. This proposal investigates this novel BCI technology that adopts an active intervention approach,
non-invasive and aims to facilitate recovery after brain injury by restoring brain function while improving
corresponding motor function.
Aims 2 & 3: To track brain reorganization changes and behavioral changes induced by BCI-FES vs.
standard FES (current standard of care) in stroke patients.
We also propose to study the mechanisms underlying functional recovery using this approach by
collecting fMRI, EEG and DTI at different time points so as to monitor the extent of brain changes and to
delineate the areas and tracts that are associated with improvement in behavior. Recent studies of
stroke rehabilitation have suggested that ipsilesional and contralesional areas and tracts play an important
role in the recovery process. These areas and tracts may be adaptive and essential for recovery
whereas others may be maladaptive. Future studies using the novel stroke rehabilitation device can be
aimed at facilitating adaptive areas/tracts and suppressing maladaptive areas/tracts in order to optimize
recovery.

Public health relevance
PROJECT NARRATIVE Stroke is the fourth leading cause of death in the United States as well as the leading cause of long-term disability. Each year about 800,000 people suffer a new or recurrent stroke in the United States. One of the common morbidities of stroke involves impairment of upper limb motor function with 1/3 of patients having residual deficits. There is a need to identify an intervention method that will restore motor function, reduce functional dependence and improve the quality of life in these patients. This proposal investigates a novel technology that adopts an active intervention approach, non-invasive and aims to facilitate recovery after brain injury by restoring brain function while improving corresponding motor function. The technology allows for an active rehabilitation approach in which brain thoughts inferred by EEG-based (electroencephalograph) Brain Computer Interface (BCI)system are linked to functional electrical stimulation (FES) of the muscles to replace or assist function that is lost in neurologically impaired individuals.